Defining the role of post-translational regulation by extracellular proteases in the pathogenesis of Staphylococcus aureus osteomyelitis

SUMMARY ABSTRACT
We have demonstrated that mutation of the staphylococcal accessory regulatory (sarA) in Staphylococcus
aureus results in an increase in the production of extracellular proteases to a degree that limits biofilm
formation, limits cytotoxicity for mammalian cells including osteoblasts and osteoclasts, and limits the
accumulation of both surface-associated and extracellular virulence factors. We have also demonstrated that
this can be correlated with decreased virulence in animal models of sepsis and osteomyelitis. Moreover, we
have confirmed that all of these phenotypes are evident in diverse clinical isolates of S. aureus and that they
can be reversed by eliminating the ability of sarA mutants to produce extracellular proteases. In this proposal,
we will expand on these observations to identify the specific extracellular proteases that are most relevant in
the context of our underlying scientific hypothesis in diverse clinical isolates of S. aureus (Aim 1) and use the
information gained to interrogate the impact of these proteases on the virulence factor repertoire on these
clinical isolates, define the impact sarA and these proteases on bone remodeling and the host response in
bone infection, and ultimately identify and evaluate the contribution of specific S. aureus virulence factors alone
and in combination with each other on these phenotypes (Aim 2).

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is a formidable bacterial pathogen capable of causing a diverse array on infections. One of the most devastating of these is osteomyelitis. The ability of S. aureus to cause these infections is dependent on having its virulence factors available in the right amount at the right time. Regulatory control at the level of the production of these virulence factors is important, but it is not the whole story. The hypothesis behind this application is that an equally important part of this story is the ability of control the production of specific extracellular proteases that modulate the turnover and accumulation of S. aureus virulence factors, and that the staphylococcal accessory regulator (sarA) plays the defining role in this regard. Identifying the most relevant proteases, and defining the manner by which they impact the S. aureus virulence factor repertoire to impact virulence and the host response in bone infection are the overall goals of this application.